The role of γδ T cells in fetal and infant immune defense against malaria

T cells expressing the γδ TCR are the first to develop during human gestation and possess many
features that make them uniquely suited to protection of the fetus and infant. Unlike conventional
αβ T cells, γδ T cells recognize non-peptide antigens and can exhibit rapid, innate-like effector
functions that are not dependent on prior antigen exposure nor on priming by dendritic cells, which
are functionally immature in early life. A subset of γδ T cells (Vγ9Vδ2) respond to phosphoantigens
produced by Plasmodium falciparum via a unique mode of presentation by ubiquitously expressed
butyrophilin molecules. Vγ9Vδ2 T cells inhibit parasite replication in vitro and are associated
with protection from P. falciparum parasitemia in vivo. Remarkably, Vγ9Vδ2 T cells that express a
phosphoantigen-reactive γδ TCR and pre-programmed effector functions are already present in fetal
blood at mid-gestation. These fetal Vγ9Vδ2 T cells have high inflammatory potential and can be
rapidly activated to produce IFNγ and granzymes upon stimulation. In addition, they express
semi-invariant TCRs with distinct sequence characteristics, including limited junctional diversity
and differential gene segment usage, that distinguish them from Vγ9Vδ2 T cells generated later in
life. Given the intrinsic reactivity of Vγ9Vδ2 T cells to P. falciparum, we hypothesize that these
cells may play a beneficial role as ready-made effectors during acute malaria infection of infants
and young children, before an adaptive immune response has developed. We will use longitudinal
samples previously collected from a large cohort of Ugandan infants, including cord blood
mononuclear cells and infant PBMCs, to determine how Vγ9Vδ2 T cells respond to malaria antigen
exposure in utero and during early childhood. In the first aim, we will characterize the expansion,
differentiation, effector functions, and proliferative capacity of γδ T cells in infants following
prenatal and postnatal malaria, enabling us to assess whether the Vγ9Vδ2 T cell response differs
based on the timing of initial malaria exposure. In the second aim, we will evaluate the impact of
malaria antigen exposure in utero and during early life on the γδ TCR sequence repertoire. This aim
will incorporate single-cell sequencing technologies that pair transcriptomic information with TCR
sequence data from individual cells, enabling us to resolve many potential sources of phenotypic
and functional heterogeneity observed at the bulk cell analysis level. Lastly, Vγ9Vδ2 T cells have
been shown to display APC-like capabilities including phagocytosis, antigen presentation, and even
priming of naive T cells. Such functions may be of particular relevance during infancy, when
professional APCs are immature and present antigen poorly. Therefore, in the third aim, we will
investigate whether Vγ9Vδ2 T cells play additional roles in the fetus and neonate, beyond their
immediate effector functions, including uptake and presentation of antigens to conventional αβ T
cells and FcR-mediated recognition of opsonized antigens.
Together, these experiments will illuminate the functional capabilities of a unique semi-innate
effector T cell population and its role in protection against malaria during early life.

Public health relevance
Project Narrative: Malaria is a leading killer of children worldwide, but efforts to develop a preventive vaccine have failed due to our limited understanding of the immune response to infection. We will investigate the role of gamma-delta T cells, a unique lymphocyte subset with innate reactivity to malaria, in protecting infants from malaria. We will determine how gamma-delta T cells respond to malaria antigens encountered before birth (using cord blood samples from infants with and without placental malaria) as well as postnatally, in response to malaria infections acquired during infancy.